Addressing Factual Inaccuracy and Unfaithful Reasoning of Large Language Models in Biomedicine and Healthcare

Large Language Models (LLMs) represent the latest advancement in Natural Language
Processing (NLP) and Artificial Intelligence (AI), holding tremendous potential to
revolutionize biomedical and healthcare applications. Extensive research has
demonstrated the effectiveness of LLMs in a range of biomedical and health
applications, ranging from medical question answering to summarizing systematic
reviews and AI-assisted disease diagnosis. However, the major barriers to applying
LLMs in biomedical and health applications are factual incorrectness – where LLMgenerated
responses are inaccurate or incomplete – and incorrect reasoning – where
LLM-generated responses lack supporting evidence, contradict existing evidence, or
even rely on hallucinated evidence. Such issues further pose the risk of propagating
errors, potentially leading to incorrect diagnosis or treatment recommendations.
Addressing these issues has been challenging, primarily due to three fundamental
obstacles: (1) from the data perspective, LLMs may capture errors from lower-quality or
unauthorized sources in the general domain data during pretraining, lack access to
accurate and up-to-date biomedical knowledge, and consequently generate inaccurate,
or outdated results; (2) from the methods perspective, there is a lack of mechanisms for
fact-checking and evidence attribution throughout the lifecycle of LLMs when applied to
biomedical and health studies, spanning from training/fine-tuning to inference and posthoc
analysis; (3) from the accountability perspective, few approaches have evaluated
their effectiveness in biomedical and health downstream applications. Our overall
objective in this proposal is to systematically address the issue of factuality and
reasoning of LLMs in biomedicine and healthcare. The specific aims include (1) from the
data perspective, establishing a self-augmentation framework to teach LLMs to
automatically select and use relevant biomedical digital resources to augment their
responses; (2) from the methods perspective, developing an LLM curator by stimulating
fact-checking and evidence attribution performed in biocuration via a multi-stage, multitask
instruction tuning pipeline; (3) from the methods perspective, introducing a steplevel
automated feedback-guided paradigm for LLMs to reflect and improve from its
intermediate responses via fact-checking and evidence attribution; and (4) from the
accountability perspective, evaluating the methods in downstream use cases. The
proposed work is expected to address factuality and reasoning issues of LLMs – the key
barrier to their use in biomedical and health domains – and make LLMs generate
accurate responses to advance biomedical discovery and healthcare. It is also expected
to refine the current development and evaluation pipelines of LLMs in biomedical and
health domains by making fact-checking and evidence attribution essential components
and providing related benchmarks, methods, and tools to facilitate the implementation.

Public health relevance
The proposed research is relevant to public health because it introduces new strategies for systematically addressing the factuality and reasoning issues of Large Language Models (LLMs) – the main barriers to using LLMs in biomedicine and healthcare applications, and posing the risk such as incorrect diagnosis or treatment recommendations. The research will establish a foundation for advancing LLMs, ensuring they provide more accurate and generalizable responses to support biomedical discovery and healthcare, refine the current development and evaluation processes of LLMs in the biomedical and health domains, and provide resources including benchmarks, methods, and tools to the community. Therefore, the proposed research aligns with the National Library of Medicine (NLM)'s mission to develop innovative biomedical informatics and data science methods, including natural language processing, artificial intelligence, and LLMs, to advance biomedical discovery and datapowered health.